Investigating neural mechanisms of interoceptive awareness in migraine

PROJECT SUMMARY
Migraine is a highly prevalent chronic pain disorder with sensory, affective, and cognitive symptoms. Many neural
systems contribute to the pathophysiology of migraine, and in particular the insula is known to play a major role
in integrating somatosensory and interoceptive signals that contribute to the experience of migraines. Despite
the insula being a hub for both interoceptive processing3 and migraine, however, little is known about the
specific role that the insula and interoceptive awareness (i.e., the capacity to attend to and regulate
internal sensations) play in the symptomology of migraines. Migraine symptoms are cyclical, with
sensitization to pain increasing throughout the interictal phase (i.e., between migraine attacks) and peaking just
before or during the attack. We propose that increased sensitivity to pain stimuli as the interictal phase
progresses might extend to interoceptive processing; our central hypothesis is that migraine is linked with
dysregulated interoceptive processing that builds over the interictal phase and peaks close to or during
the next migraine. The research project proposed in this Small Research Grant (R03) Award will use functional
magnetic resonance imaging, measures of interoceptive awareness, and daily tracking of migraine phase and
symptom severity to understand the role that interoceptive awareness plays in the time course of migraine. We
will measure brain response during interoceptive attention among both people with episodic migraine and healthy
control participants. Participants will focus on sensations from their heart or lungs, and brain response during
this condition will be contrasted with the response during external attention to sounds and visual patterns. We
will collect data about participants’ migraine phases and symptoms using daily electronic headache diaries, and
use this to time-lock each MRI scan relative to participants’ migraine cycles. The specific goals of this proposal
are to 1) Examine associations between insula response to interoceptive attention and migraine cycle phase
in people with episodic migraine; and to 2) Investigate differences in brain response to interoceptive attention
between people with episodic migraine and healthy control participants. This award will contribute to our
understanding of the pathophysiology and time course of episodic migraine, and may identify novel neural
mechanisms of interoceptive awareness that can be targeted in clinical interventions for migraine.

Public health relevance
PROJECT NARRATIVE Migraine is characterized by dysregulation of the autonomic nervous system, including functional and structural alterations of the insula, and by sensitization to pain and interoceptive sensations such as nausea as a function of the phase of the episodic migraine cycle. The aim of this proposal is to investigate whether neural mechanisms of interoceptive awareness are altered in individuals with episodic migraine, and to what extent interoceptive awareness varies across phases of the episodic migraine cycle. In the proposed project, we will use functional MRI to compare brain response in the insula during an interoceptive attention task between people with episodic migraine versus healthy control participants, and will examine how that response varies across phases of the migraine cycle.